Ultra-dense ceramic scintillator for BrainPET scanner

Summary
Positron emission tomography (PET) is a powerful tool for imaging a wide range of biological
processes in vivo and for detecting and monitoring human disease, as well as an important
technique in neuroscience research. For human brain studies, PET offers a sensitive and
noninvasive window into brain metabolism and neurochemistry, providing information from living
human subjects that cannot be obtained using any other technique. The key characteristics of
brain PET are spatial resolution and sensitivity. Brain PETs with a spatial resolution approaching
1 mm at the center of the field-of-view (FOV) are under development using LYSO or LSO
scintillators, which are the currently available scintillators that can provide the best overall
performance. However, to obtain a high sensitivity, which strongly affects the quantitative
precision of PET imaging, L(Y)SO with a thickness of around 20 mm is widely used.
The first and the major drawback of using the thick L(Y)SO crystal is the parallel error, which
decreases the spatial resolution off the center of the FOV. Depth-of-Interaction (DOI) information
can be used to improve spatial resolution off the center of the FOV, however, the best DOI
resolution from 20 mm thick L(Y)SO is ~2.0 mm obtained using the dual-ended readout, which is
not good enough. The second drawback of the L(Y)SO is the high cost. For most scanners, the
L(Y)SO cost is half of the total scanner cost.
The performance of brain PET scanners can be improved using a new scintillator based on
Lu2O3 (LO), which has a higher density (9.4 vs. 7.4 g/cm3 for LSO) and higher effective Z (68 vs.
65 for LSO). When doped with La3+ and Yb3+, it exhibits an ultra-fast rise time (<0.6ns) combined
with prompt charge transfer luminescence with decay time of 1.7 ns, giving timing resolution (TR)
of 180 ps FWHM. The energy resolution at 511 keV is better than 10% (>10% for LYSO), due to the
good light yield from slower components (<20,000 ph/MeV) and good proportionality (better than for
LYSO). Hence, LO:La,Yb can be an excellent choice for a brain PET scanner requiring high
sensitivity and high spatial resolution. The LO is produced using ceramic methods which may
also have an edge over the crystal growth methods in terms of cost of manufacturing.
Therefore, for this project, we propose to 1) optimize the LO:La,Yb and its manufacturing for
high-resolution and high-sensitivity brain PET applications, 2) optimize LO:La,Yb based PET
detector for brain PET through experimental evaluation, and 3) to estimate the performance of a
full brain PET system based on these results through GATE Monte Carlo simulations and
benchmark it against LYSO system.

Public health relevance
Narrative The scintillator is the key part to determine the performance of the PET scanner. Lutetium oxyorthosilicate (LSO) or lutetium yttrium oxyorthosilicate (LYSO) are the most widely used scintillator materials in state- of-the-art PET scanners, however, L(Y)SO are not perfect for applications such as high-resolution and high- sensitivity brain PET scanners, due to their 7.4 g/cm3 density requiring thick material to achieve high- sensitivity and high cost. This project aims to develop and verify a new scintillator with higher density (9.4g/cm3) and lower cost for the next-generation brain PET scanners with unform 1 mm spatial resolution across the field-of-view and higher sensitivity.